Mechanosensing mechanisms at the intestinal surface

Summary/Abstract
A monolayer of epithelial cells lines pathways that are exposed to the external environment, such as the
respiratory tract and digestive system, sequestering them from damaging external factors and acting as sensors
of environmental changes. Microvilli, arrays of membrane bound actin protrusions that decorate the apical
surface of almost all epithelial cells, form critical points of first contact between the epithelial cell and luminal
contents. Here, microvilli play important roles in sensing and responding to chemical and mechanical stimuli. Yet
the signaling-associated machineries within microvilli that drive these critical physiological functions, especially
those that sense or respond to mechanical forces, are not well understood, representing a key knowledge gap.
A major limitation has been that research on microvilli is predominantly conducted in cell culture model systems,
which lack the 3D spatial ecosystem and mechanochemical signaling of cells within tissues, in vivo. We are
uniquely positioned to overcome this hurdle by combining super-resolution functional imaging of microvilli in live
animals and in vivo interactomics. We have identified novel ion channels that localize to epithelial cell microvilli
across organs and are promising candidates that mediate mechanochemical signaling. We have also developed
an in vivo systems approach to identify new microvillar associated signaling molecules. In this research program
we will ask: 1) what are conserved molecular machineries that drive mechanochemical sensing in epithelial
microvilli? 2) what are physiological consequences of microvillar signaling function across scales, from cell to
organism? and 3) how does in vivo environment impact microvillar signaling inputs/outputs? This research will
thus provide much-needed conceptual advances in our understanding of microvilli-mediated signaling in
epithelial physiology and shed new light into the role of epithelial dysfunction in allergic and autoimmune disease.

Public health relevance
Project Narrative Microvilli are protrusions on the surface of epithelial cells that form the primary interface between our bodies and external environment. At this site they play critical roles in sensing and responding to various mechanical and chemical signals that are important for epithelial homeostasis and disease, yet, signaling machineries and mechanisms remain to be identified. Over the next five years, the current application will explore a compelling overarching hypothesis that microvillar-mediated signaling is regulated by novel mechanosensory ion channel proteins that localize to microvillar tips.